Developing novel strategies to increase COVID-19 testing among underserved and vulnerable populations in West Virginia through community and state partnerships

West Virginia (WV) is rated by Becker’s Hospital Review as the state with the sixth most vulnerable population to the novel coronavirus (SARS CoV-2) while a second group at Wallethub, using three key domains (medical, housing, financial), rates WV as the most vulnerable state to SARS CoV-2 impact. Central to the state’s extreme vulnerability is the high prevalence of obesity, cardiovascular disease including hypertension, chronic lung disease due to smoking and environmental exposure (e.g., mining), diabetes mellitus, and cancer. Additionally, WV is among the three states having the highest proportion of persons > age 65 years (20%). Through school and university closures in March 2020, along with shutdown of non-essential businesses, WV had relatively few COVID-19 cases and deaths until July 2020 when transmissibility (Rt) skyrocketed. Testing remains problematic in WV for multiple reasons, including inadequate testing supplies, accessibility to testing sites (given the rurality of the state and lack of widespread public transportation), shortages of personal protective equipment for staff, and lack of insurance coverage for surveillance testing and for uninsured persons. The West Virginia Clinical and Translational Science Institute (WVCTSI) is submitting this application in partnership with multiple organizations with which they have existing collaborative relationships, including: 1) the WV Practice Based Research Network (PBRN), a 107 site primary care network spanning the state, 2) the WV Department of Health and Human Resources, 3) the WV National Guard, 4) West Virginia University (WVU) Health Sciences Center and College of Engineering, and 5) the Partnership of African American Churches (PAAC). Critically important is the generous match of $1.5 MM that the state of WV is offering to this initiative should this supplement receive funding. Vulnerable populations addressed in the application include individuals in rural communities and African American populations as well as those with comorbidities known to increase risk of severe COVID-19. Given the high prevalence of substance use disorder (SUD) in WV, a cross-cutting theme is ensuring persons with SUD are included in all proposed strategies to increase SARS CoV-2 testing. We will address COVID-19 testing disparities through achievement of the following specific aims, all of which use nucleic acid polymerase chain reaction testing on nasal or nasopharyngeal swabs: 1) Enhance COVID-19 testing among rural primary care offices located across WV, 2) Intensify COVID-19 testing through mobile vans in areas forecasted to experience a near-term increase in COVID-19 incidence, and 3) Increase COVID-19 testing in Black or African American communities through a dedicated mobile van and home testing. Evaluation of implemented strategies includes assessing numbers of tests performed, uptake of home testing, satisfaction surveys, and structured interviews among Black or African Americans enrolled in the home testing study.

Public health relevance
The purpose of this proposal is to implement collaborative strategies to increase availability and uptake of SARS CoV-2 testing among the medically underserved, rural WV population that includes multiple vulnerable groups at risk for severe COVID-19 disease and death. These vulnerable groups include the Black/African American population, patients with high comorbidities, and persons who inject drugs. This initiative will test whether or not those implemented strategies, including home test kit and mobile unit mechanisms, successfully increase testing, and if not, to determine why the interventions did not work so as to inform future sustainable testing policy.